Transcriptional Regulation of Peripheral Immune Cells as a Modulator of Melanoma Immunotherapy Resistance and Toxicity

PROJECT SUMMARY Melanoma is the fifth most common cancer in the US and while the prognosis for early-
stage melanoma is favorable, late-stage disease was long considered incurable. Immune checkpoint inhibitors
(ICIs) have revolutionized metastatic melanoma treatment; nevertheless, ~40% of patients still do not respond
to therapy and ~80% of ICI-treated patients experience immune-related adverse events (irAEs). Identifying
reliable pre-treatment biomarkers stratifying patients for maximal efficacy while minimizing toxicity is an urgent
clinical task, as existing tumor or tumor/immune surrogates are limited. Recent research suggests that baseline
host immunity is controlled by specific regulatory networks impacting T-cell activation and differentiation,
including CD8+ T cells (the primary targets of ICI). Accumulated data show that the regulatory genome (the
“regulome”), composed of transcription factors, enhancers, and other elements (e.g. lncRNAs), controls the
transcriptional reprogramming of cytotoxic T-cells, playing a critical role in host anti-tumor immune response.
We and others have reported that the regulome is enriched by underlying genetic variation associated with
autoimmune risk and that this genetic susceptibility associates with ICI outcomes. Based on these intriguing
observations, I hypothesize that baseline “regulome” states of peripheral immune cells, determined by the
interplay of inherited genomic and transcriptomic factors, represent novel biomarkers of ICI resistance and
susceptibility to irAEs. I postulate that these transcriptional regulatory networks (TRNs) govern T cell activity,
potentially revealing biological pathways to reduce toxicity and enhance ICI efficacy. For the F99 phase, I will
develop a genomic approach capturing TRNs of pre-treatment peripheral CD8+ T-cell (pre-pCD8+) activity as
surrogates of ICI efficacy in metastatic melanoma using samples from ICI-treated metastatic melanoma
patients from a large clinical trial led by Bristol-Myers Squibb. I will identify transcriptional signatures
associated with ICI outcomes in pre-pCD8+ cells; single-cell RNA-seq will offer insight into immune cell
subtypes in the ICI context (Aim 1.1). Combining Assay for Transposase-Accessible Chromatin (ATAC)-seq,
RNA seq, and whole-genome sequencing, I will determine CD8+-specific regulome TRNs as modulators of ICI
outcomes in advanced melanoma patients (Aim 1.2). For the K00 phase, I will expand this hypothesis to
explore pre- and post-treatment changes at the single-cell level, correlating alterations in specific immune cell
types with ICI response and irAEs using melanoma patient PBMCs (Aim 2). I will also develop models linking
ICI-associated single-cell PBMC cell types and transcriptomic signatures with specific tumor neo-epitopes for
therapeutic targeting. Identifying patients most likely to respond to ICI using these biomarkers may also point to
novel biological pathways for more efficacious and less toxic treatments, further improving ICI patient
outcomes in melanoma and potentially other cancers.

Public health relevance
PROJECT NARRATIVE Despite recent advances in melanoma immunotherapy treatment, we still do not know why some patients do not respond to immune checkpoint inhibitors (ICI) and some experience severe immune-related side effects. I propose to study the genetic changes within ICI-specific immune cells to discover novel predictive biomarkers for ICI response and toxicity to better stratify patients for maximal efficacy and minimally toxic outcomes.